Exposure to Per- and Polyfluoroalkyl Substances and Prostate Cancer: Opportunities for Prevention and Early Detection

PROJECT SUMMARY
Prostate cancer (CaP) is the leading non-cutaneous cancer in men, accounting for roughly 1 in 5 new cases and
1 in 10 deaths from cancer per year. Few modifiable risk factors have been identified for CaP, limiting
opportunities for primary prevention. In the US, Black men experience over twice the rate of mortality from CaP
compared to White men, disparities that are partly explained by differences in neighborhood environmental
context. Black men are often exposed to higher burden of environmental pollutants due to segregation and
neighborhood disinvestment, which may contribute to disparities. Per- and polyfluoroalkyl substances (PFAS)
are synthetic industrial chemicals of public health concern due to their ubiquitous presence and persistence in
the body and environment, as well as growing evidence of their adverse health impacts. Certain PFAS have
been classified as Group 2B (“possible”) carcinogens by the Institute of Agency for Cancer. Some studies in
populations with high occupational or community exposures to PFAS have shown elevated risk of CaP, but few
studies have examined these associations in large racially-diverse, population-based studies. I propose to study
three commonly measured PFAS (PFOA, perfluorooctane sulfonate (PFOS), and perfluorononanoic acid (PFNA)
as potential risk factors for aggressive CaP and CaP disparities in New Jersey. I will develop a spatiotemporal
model of drinking water PFAS exposure using multiple geographic datasets capturing business, hydrology,
meteorologic, and census variables. Modeled PFAS exposure will be linked to masked residential address
histories collected from men diagnosed with CaP in the New Jersey State Cancer Registry to estimate the risk
of advanced CaP associated with increasing levels of PFAS. I will then conduct a pilot study among patients
seeking CaP treatment at the Rutgers Cancer Institute of New Jersey. I will evaluate differences in PFAS souces
by different sociodemographic groups, and study associations between serum PFAS and risk of biochemical
reccurrence among men treated for CaP. This research will be complemented by a training program to develop
knowledge and skills in health effects of endocrine-disrupting chemicals, spatiotemporal modeling of
environmental chemicals, primary data collection and biospecimen collection, and molecular alterations involved
in prostate carcinogenesis. I have invited a multidisciplinary team of environmental and cancer researchers to
support my training. My short-term goals are to develop expertise in pathways through which PFAS and related
endocrine-disrupting chemicals influence CaP, and disseminate findings through conference presentations and
publications. My long-term goal is to become an independent scientist and expert in multilevel environmental
and biological pathways that influence CaP progression and outcomes. Preliminary data generated through this
project will support the development of an R01 proposal to clarify mechanisms through which PFAS and other
endocrine-disrupting chemicals influence tumor biology and risk of recurrence following treatment for CaP.

Public health relevance
PROJECT NARRATIVE Per- and polyfluoroalkyl Substances (PFAS) are chemicals that are widely used in industrial and commercial activities, and of growing concern due to persistence in the body and environment and emerging evidence of carcinogenic effects. Higher PFAS exposure may increase risk of prostate cancer (CaP), the most commonly diagnosed non-cutaneous cancer and second leading cause of cancer-related death in US men, but few large, population-based studies have tested this hypothesis in a racially and socioeconomically diverse population. This study builds on prior work to examine environmental causes of racial disparities in CaP using registry- based cohort data to link a spatiotemporal model of drinking water exposure to PFAS to estimate impacts on aggressive CaP incidence, and will investigate sources of PFAS exposure and potential influences on biochemical recurrence of CaP in a pilot study of survivors.